INTRAVENOUS SPIRAMYCIN IN AIDS PATIENTS WITH CRYPTOSPORIDIAL DIARRHEA

This is a single-blind study to determine the safety and efficacy of 3.0 or 4.5 MIUs of spiramycin administered intravenously every 8 hours in subjects with AIDS-related cryptosporidial diarrhea.